OPIOID NEUROTRANSMISSION AND RISK OF ALCOHOLISM

This is a pharmacologic challenge study that uses naloxone vs. placebo to examine the opioid regulation of ACTH release as a marker for risk of alcohol dependence. Problems with the study have now been resolved; we have resumed running subjects in this protocol.